Alterations & Renovations - Hawaii Pacific University

ALTERATIONS AND RENOVATIONS SUMMARY
Building on prior successes, partner institution Hawaii Pacific University (HPU) requests funds for renovations
that will support the goals and objectives of the proposed INBRE V renewal. Prior INBRE grants have supported
and inspired the development of the biomedical sciences at HPU. The impacts on the HPU Department of
Natural Sciences have been transformational and sustained, and are now culminating in a major expansion of
research and instructional lab space that is currently under construction on HPU’s downtown Honolulu campus.
With this success, HPU is now looking to expand the scope of its biomedical research by expanding the lab
resources for its new Biomedical Engineering program. HPU’s Engineering program, which just graduated it first
cohort in Spring 2022, has strong growth potential with plans to hire 2 additional Biomedical Engineering faculty
in the coming years. The program currently has access to 3 research labs totaling 700 sq ft at HPU’s Waterfront
Plaza facility. Here, HPU proposes to create a new 300 sq ft Biosafety level 2 research lab in space contiguous
with the current engineering labs, a 40% increase in lab space. The lab will feature all cleanable finishes, fixed
cabinetry, a dedicated hand wash sink, an eye-wash, proper lighting and electrical capacity, and all necessary
mechanical and HVAC modifications. Existing equipment to equip the lab includes a top-load autoclave, a 4 ft
biological safety cabinet, and a -80 °C freezer. The facility will be managed jointly by the INBRE-funded Shared
Instrumentation Facility and the engineering faculty users. This lab will provide an essential expansion of
laboratory space for the Biomedical Engineering program and provide additional space for HPU’s Student
Research Experiences (SRE) activities. In light of HPU’s hiring plans, this new lab will enhance HPU’s ability to
attract high quality biomedical engineering faculty and increase the opportunities for undergraduate biomedical
research. The renovation will add capacity that will also help cultivate new SRE mentors as well as potentially
attract a future INBRE Junior Investigator. The expansion of research resources at HPU in bioengineering will
also foster collaborations within HPU and with other INBRE partner institutions. The aim of this proposal is:
Specific Aim: Create a 300 sq ft Biosafety Level 2 laboratory to support undergraduate research in the HPU
Biomedical Engineering program.